Leveraging mutational analysis of cell-free DNA to identify carcinogenic exposure and enable early detection of cancer

PROJECT SUMMARY / ABSTRACT
Preliminary work has shown that two different environmental hepatocarcinogens, aflatoxin B1 (AFB1) and
N-nitrosodimethylamine (NDMA), produce high-resolution mutational spectra (HRMS) that occur shortly after
carcinogen exposure, are distinct from one another, and are mechanistically in accord with the established
mutational properties of the DNA adducts these agents form. Extending that work, the goal of the proposed
project is to develop a “blood-based” analytical tool enabling rapid detection of the mutational profiles of these
agents. The hypothesis to be tested is that mechanistically informative mutational fingerprints of environmental
toxicants are present in circulating cell-free DNA (cfDNA) obtained from blood of exposed individuals. This
project will address a gap in knowledge connecting environmental exposures to cancer risk.
Sequencing of cancer genomes has revealed ~100 mutational patterns termed “signatures,” with some
signatures showing similarity to mutational spectra produced by known environmental carcinogens (e.g., UV
light, AFB1, benzo(a)pyrene). Currently, there is no facile way to measure the genetic consequences of prior
genotoxic exposures because of: (1) the invasive procedures required to obtain tissue samples, and (2) the
insensitivity of “typical” DNA sequencing methods. This proposal will take advantage of recent advances to
overcome these limitations. Consisting of fragments ~170 bp long, cfDNA originates from normal cell turnover
as well as from apoptotic and necrotic cells following exposure to toxins. Conventional NextGen DNA sequencing
tools cannot reliably identify the low levels of mutations that are present in cfDNA. To overcome this sensitivity
limitation, we shall use Duplex Consensus Sequencing, which we have shown affords up to 104-fold higher
accuracy/sensitivity over conventional sequencing.
The Specific Aims will determine if HRMS previously observed in mouse liver genomic DNA following
treatment with AFB1 and NDMA can be identified in cfDNA in blood. Aim 1 will quantify the levels of cfDNA in
blood after treatment. Circulating cfDNA will be assayed at several times after treatment to determine the
temporal relationship between exposure, hepatotoxicity and the levels of cfDNA in blood. Aim 2 will determine
compound-specific mutational spectra in cfDNA and compare them to spectra obtained from genomic DNA from
target tissue (liver) as well as white blood cells from blood, lymph nodes and thymus. Aim 3 will examine
mutational spectra in liver-specific cfDNA generated by challenging the animals with mild hepatotoxicants (e.g.,
ethanol, acetaminophen), which trigger increased cell turnover. The success of these studies will provide an
innovative approach to mutational fingerprinting of environmental exposures that could, in turn, lead to predictive
biomarkers that would trigger interventions to limit future exposures and reduce healthcare needs by preventing
the development of advanced disease.

Public health relevance
PROJECT NARRATIVE Many environmental carcinogens are agents that damage DNA in target cells, creating characteristic patterns of mutations called “mutational signatures”, which are often found in human tumors. By leveraging a highly-sensitive sequencing technology, this proposal focuses on the development of a blood-based analytical method that can identify environmental carcinogen exposure by their mutational imprints found on circulating cell-free DNA in the blood. The identification of such biomarkers of carcinogen exposure can subsequently guide cancer risk assessment, mitigate further exposure and enable early screening/early detection of cancer in high risk individuals.